Bioinformatics Tools and Services for Antimicrobial Resistance Research

This agreement between the National Institute of Allergy and Infectious Diseases and the National Library of Medicine provides research tools and resources to help advance research on antimicrobial resistance.